2/2 Allopregnanolone and Dynamic GABA-A Receptor Plasticity in Selective Serotonin Reuptake Inhibitor Responsive Premenstrual Dysphoric Disorder

PROJECT SUMMARY
Premenstrual dysphoric disorder (PMDD) is a severe affective disorder impacting millions of women worldwide,
thought to be due to impaired sensitivity to hormone fluctuations across the menstrual cycle. Low-dose selective
serotonin reuptake inhibitors (SSRIs) are the first-line treatment for PMDD, but their mechanism in PMDD is
poorly understood. Despite this morbidity and limited treatment options, research on PMDD’s pathophysiology
and treatment lags behind that of other brain disorders. A potential aspect of PMDD’s pathophysiology is altered
interaction between steroid hormones - specifically gamma-aminobutyric acid (GABA)ergic neuroactive steroids
(NAS) - and their target, the GABA-A receptor (GABA-A-R). GABAergic NAS, such as the progesterone
metabolite allopregnanolone, fluctuate across the menstrual cycle and are associated with luteal phase symptom
emergence in PMDD. The proposed study will examine three aspects of GABAergic function in PMDD, to
clarify its pathophysiology: 1) GABAergic NAS fluctuations, particularly allopregnanolone (ALLO) and its
isomers, 2) GABA-A-R subunit expression, and 3) GABAergic neurosteroidogenic enzyme expression. A key
focus of this placebo-controlled trial is to assess how these parameters are affected by low-dose SSRI
treatment in women with PMDD, shedding light on treatment mechanism. In this multi-site study, we will assess
288 women with regular menstrual cycles (72 controls, 216 with PMDD), across the luteal phase of the menstrual
cycle. In a second luteal phase, women with PMDD will be randomized to sertraline or placebo. We will capture
three outcome measures: 1) plasma NAS changes within subjects at multiple timepoints across the luteal phase
using precise gas chromatography/mass spectrometry (GC/MS) methods, 2) GABA-A-R subunit expression
across the luteal phase in blood cells measured via real-time polymerase chain reaction (RT-qPCR), and 3)
GABAergic neurosteroidogenic enzyme expression. We will compare controls versus women with PMDD, and
within those with PMDD compare sertraline versus placebo. The study explores a mechanistic hypothesis about
NAS dynamics and GABA-A-R plasticity in women with PMDD, and focuses on biologically relevant treatment
target engagement. The multiple investigators bring complementary expertise; Drs. Hantsoo and Payne in
prospective studies of reproductive affective disorders, and Dr. Pinna in applying state-of-the-art methods to
study the impact of NAS on GABA-A-R function. This study represents a critical step in elucidating NAS and
GABA-A-R dynamics in women with PMDD when treated with low-dose SSRIs, which may shed light on both
pathophysiology and treatment response mechanisms. Understanding PMDD’s pathophysiology may also
inform treatment development, i.e.GABA-modulating drugs that have recently emerged as treatments for
postpartum depression. Assessing parameters affected by SSRI in PMDD could lead to developing a
personalized medicine approach.

Public health relevance
PROJECT NARRATIVE Although neuroactive steroids (NAS) and the gamma-aminobutyric acid-A receptor (GABAAR) are thought to be involved in the serious affective disorder premenstrual dysphoric disorder (PMDD), comprehensive studies in humans are lacking. We propose to study the concentrations of GABAergic NAS and ratios of NAS to their precursors, expression of the rate-limiting neurosteroidogenic enzymes, and expression of GABAAR subunits across the luteal phase in controls and PMDD, and within PMDD among those who receive a low-dose selective serotonin reuptake inhibitor (SSRI) versus placebo. The results will provide a comprehensive view of the dynamic changes in these systems across the menstrual cycle and will add to our understanding of the mechanisms that underlie PMDD, as well as therapeutic mechanisms of the first-line PMDD treatment, low-dose SSRI.